CellScape ChipCytometry System for High-Parameter Cellular Phenotyping

Project Summary/Abstract
This request is for funds to purchase a Canopy Biosciences CellScape instrument to fill a critical void
in highly multiplexed spatial biology capabilities, becoming the only instrument of its kind on the Wayne
State University (WSU) campus. The purchase of this instrument will directly support scientific
advancement of NIH-funded research in cancer, metabolic disorders, and infectious diseases of the eye
and allow our Users to perform deep analysis of various pre-clinical and patient sample types for better
understanding of disease development and identifying new treatment options. The CellScape instrument
will be housed within the Microscopy, Imaging, and Cytometry Resources (MICR) Core, a centralized
instrumentation core facility of WSU and the Karmanos Cancer Institute (KCI). The MICR Core staff has
extensive experience in all aspects of flow cytometry, confocal microscopy, and small animal imaging
and currently serves over 75 PIs and 125 individual Users, both internal and external to WSU. While the
MICR Core is well-equipped with several flow cytometry analyzers/sorters and light microscopy systems,
the CellScape instrument will allow us to bridge these two technological arms of our core and introduce
a new breadth and depth to the research capabilities of our facility. 16 PIs have been identified for the
proposed instrument, 6 Major Users and 10 Minor Users. These 16 PIs have over $20M in NIH-funded
direct costs from at least 5 different institutes. The new instrument will be maintained by the MICR Core
which has extensive infrastructure and expertise in place to oversee User training, assay development
and troubleshooting, instrument operation, data analysis, and maintenance.

Public health relevance
Project Narrative The purchase of a Canopy Bioscience CellScape instrument for highly multiplexed spatial biology imaging will directly support scientific advancement of NIH-funded research in cancer, metabolic disorders, and infectious diseases of the eye. This instrument will allow our Users to perform deep analysis of various pre-clinical and patient sample types to better understand their functions and develop new treatment options for these diseases.